The Role of TGF-beta Activation and Signaling in Aortic Stenosis Progression

PROJECT SUMMARY
Aortic stenosis (AS) is a degenerative heart condition characterized by fibrosis and narrowing of the aortic valve. AS
causes increased wall shear stress across the aortic valve, making the heart work harder to pump blood through
the narrowed valve opening. These effects can cause heart failure and death. The only current treatment for AS is
valve replacement, an invasive and risky procedure. Our long-term goal is to improve the understanding and
treatment of fibrosis, which underlies AS. Transforming growth factor-β1 (TGF-β1) is a multifunctional cytokine that
induces pathologic organ fibrosis in many disorders. Cells secrete latent (L)TGF-β1, and increased plasma levels
of LTGF-β1 have been associated with AS in humans and in a mouse model of AS. We showed that wall shear
stress can dramatically activate LTGF-β1 released from platelets in vitro. However, the mechanism of TGF-β1
activation in vivo and its signaling on valvular cells in AS remain poorly understood. The objective of this
application is to determine the mechanism of LTGF-β1 activation in vivo and identify the cell types to which TGF-
β1 signals, leading to their mesenchymal transition and subsequent AS progression. Platelets are the major source
of plasma LTGF-β1, as they contain more than 100 times as much LTGF-β1 as other cell types, and our preliminary
data show that platelets are physically attached to isolectin B4-positive valvular cells, presumably valvular
endothelial cells (VEC) undergoing mesenchymal transition and giving rise to collagen-producing myofibroblasts
in an AS mouse model. These results led to our central hypothesis that wall shear stress activates platelet-derived
TGF-β1, which stimulates isolectin B4-positive cells (VECs and/or macrophages) to undergo mesenchymal
transition, thereby producing excessive collagen and leading to AS progression. Furthermore, TGF-β1 may
represent a previously unrealized clinical indicator of AS progression. We propose the following Specific Aims: (1)
Determine whether wall shear stress activates LTGF-β1 in vivo; and (2) Determine whether TGF-β1 signaling in
valvular cells leads to mesenchymal transition and AS progression. Our proposed studies will clarify the
mechanism of TGF-β1 activation in vivo and the cell types on which TGF-β signals, leading to mesenchymal
transition and AS progression. We will use innovative, sensitive techniques to evaluate AS development in
mouse models and to measure active TGF-β1 levels in plasma samples from AS patients. Furthermore, the
proposed research will explore the mitigation of AS progression using two low-dose small-molecule inhibitors of
TGF-β1 activation and signaling. Our pre-clinical assessment of TGF-β1 activation and signaling in AS patient
samples will be crucial for prospective clinical studies on the use of TGF-β1 as a biomarker of AS. Overall, our
proposed studies will provide a more complete understanding of the role of TGF-β1 in AS, which may establish
TGF-β1 as a novel target for drug development and a potential biomarker of AS and other fibrotic diseases.

Public health relevance
PROJECT NARRATIVE Aortic stenosis (AS) affects many elderly Americans and is an independent risk factor for heart failure, the leading cause of death in the U.S. Currently, the only treatment for AS is invasive and risky valve replacement. The proposed research seeks to better understand the mechanisms of AS progression and to develop urgently needed new diagnostic, prognostic, and therapeutic approaches for AS.